Clinical Trial Readiness for the Evaluation and Treatment of Neuropsychiatric Manifestations in Tuberous Sclerosis Complex

SUMMARY ABSTRACT:
Neuropsychiatric and neurodevelopmental manifestations, including closely related autism spectrum disorder
(ASD), intellectual disability (ID), and other neurobehavioral difficulties, are prominent in the majority of patients
with Tuberous Sclerosis Complex (TSC). Collectively, the intertwined constellation of these cognitive,
neurobehavioral deficits, including sleep and sensory impairments, is referred to as TSC-associated
neuropsychiatric disorders (TAND). There is a lack of TAND-specific treatments studied for use in TSC. The
Developmental Synaptopathies Consortium (DSC) seeks to address this need by addressing critical gaps in
clinical trial readiness for developing potential therapies (pharmacological and non-pharmacological) for TAND
in TSC. Over the last five years, this has included development of the self-administered and quantified version
of the TAND Checklist (TAND-SQ) in collaboration with the TANDem consortium and piloted work on novel
electrophysiological biomarkers for ASD and ID in TSC. Over the next five years, we plan to validate the TAND-
SQ for use in future clinical trials (AIM 1). We also will conduct the first prospective longitudinal assessment of
psychiatric conditions and mental health symptoms in TSC, along with establishing the landscape of psychotropic
medication use, in TSC patients with TAND (AIM 2). Finally, we will newly characterize sleep difficulties and
abnormalities in sensory processing within the TAND phenotype and further develop corresponding
electrophysiological biomarkers of each as potential measures of abnormal neuronal circuitry contributing to the
pathobiology of TAND in TSC and their potential suitability for use in future clinical trials (AIM 3). The proposed
research will also improve our understanding of the neurobiology of neurodevelopmental disorders such as ASD
and ID and aid in developing treatments for these disorders more broadly.